2024 Cell Death Gordon Research Conference and Gordon Research Seminar

Abstract
We intend to request funds to help support the 2024 Gordon Research Conference (GRC) on Cell Death to be
held July 28-August 2, 2024 and its associated Gordon Research Seminar (GRS) to be held July 26-27,
2024 at the
Jordon Hotel at Sunday River, US
. The Cell Death GRC is among the most highly regarded
international conferences in the cell death community. Participants will give oral presentations, lead
discussions or present their work in poster format. In keeping with the intimate spirit of the Gordon
Conference, attendance will be limited, and presentations will feature unpublished work at the leading edge of
this field. The overall goal of this conference is to expedite progress in cell death research and to use research
findings for the development of new anti-inflammatory and anti-cancer therapies. A secondary goal is to
facilitate collaborations among cell death researchers and investigators in complementary basic, translational
and clinical fields. The “Power Hour” during the GRC will provide a platform to address challenges trainees at
all levels encounter, especially for those who are from under-privileged minority groups. The GRS target
audience are students and postdoctoral trainees. The GRS provides trainees with the opportunity to present
their work in a more peer-to-peer setting. The GRS will also have a few established faculties from industry and
academia who will provide career counseling and advice to the trainees. We believe the GRS will provide the
platform to help trainees launch their own independent research career.
The aims of this conference are to: 1) gather established experts, junior scientists and researchers new to this
field in a setting that supports structured and casual interactions. 2) promote exchange of cutting edge,
innovative and unpublished science relevant to the roles of cell death in healthy and pathologic contexts. 3)
expedite discoveries that advance mechanistic knowledge on cell death and facilitate clinical opportunities for
the treatment and diagnosis of diseases caused by the dysregulation of this process.
The major themes of the meeting will focus on: 1) fundamental mechanisms of different cell death modalities,
2) cell death in inflammatory disorders, 3) host-pathogen interactions, 4) the cross-talk between cell death and
immunity, 5) Targeting cell death mechanisms in disease, 6) Inflammation and tissue homeostasis. The
meeting will facilitate the alignment of recent breakthrough discoveries with the development of new therapies
for infections, immunological disorders, and cancers.

Public health relevance
Project Narrative Excessive, reduced or inappropriate cell death often lead to inflammation and is frequently found in many diseases. The 2024 Gordon Research Conference and Gordon Research Seminar on Cell Death will provide a platform for unencumbered scientific exchange, focusing on mechanisms that regulate different cell death modalities and how they impact on host-pathogen interactions, inflammatory diseases and cancer. The conference will foster career development of trainees at all levels, accelerate discovery in these areas, and advance new opportunities for therapeutic intervention in cell death-associated illnesses.